Replacing Invasive Cystoscopy with Urine Testing for Non-muscle Invasive Bladder Cancer Surveillance

Project Summary
There are ~800,000 bladder cancer survivors in the US, making it the fifth most prevalent cancer. This study
focuses on the largest group of patients with bladder cancer, the 79% with non-muscle invasive early-stage
cancer. Per current guideline recommendations, these patients undergo transurethral endoscopic resection
followed by surveillance cystoscopy every 3 to 6 months, making cystoscopy common with over a million
procedures per year. Cystoscopy entails direct inspection of the bladder via a cystoscope that is inserted into a
patient's urethra. It can be quite uncomfortable as it is performed in non-sedated patients. In spite of this
burden on patients, high-quality data on the benefits of high-intensity surveillance cystoscopy are lacking. The
experts writing the guidelines recognized the unclear benefit of high-intensity surveillance and specifically
stated: “There is an urgent need for studies to determine if less stringent follow-up regimens can be employed
without significantly affecting oncologic outcomes in these patients.” Replacing cystoscopy with less invasive
urine testing is such a less stringent follow-up regimen. Preliminary data show that the urine tests Xpert
Bladder Cancer Monitor (mRNA-based) and Bladder EpiCheck (DNA methylation test) may replace cystoscopy
procedures, given their high sensitivities. However, with a specificity 0.76 and 0.84, up to one out of four tests
may be false positive, so many patients still have to undergo cystoscopy for positive tests. Thus, longitudinal
comparative data are needed before these tests can be considered for routine care. Specifically, we need
evidence that programmatic surveillance with urine tests significantly decreases the burden of surveillance for
patients and has acceptable oncologic outcomes in diverse populations of bladder cancer survivors. Here, we
will define the extent to which patients' burden of surveillance can be reduced with bladder cancer urine tests.
We propose a three-site randomized phase 2 trial including 240 patients with early-stage bladder cancer. After
a normal surveillance cystoscopy at study entry, patients will be randomized 1:1:1 to programmatic surveillance
with the Xpert bladder cancer urine test, the Bladder EpiCheck urine test, or standard cystoscopy. We will
(1) determine whether burden of surveillance is significantly decreased in the urine testing arms versus
standard cystoscopy, (2) compare short-term safety outcomes in the urine testing arms versus standard
cystoscopy at 1 and 2 years, and (3) estimate important feasibility data for a subsequent large non-inferiority
comparative effectiveness trial. In summary, we will systematically study whether the burden of surveillance
cystoscopy can be improved among bladder cancer survivors by replacing invasive cystoscopy with urine
testing, ultimately improving their quality of life. If bladder cancer urine tests significantly decrease the burden
of surveillance, our data will provide a strong justification for a subsequent comparative effectiveness trial of
programmatic surveillance with urine testing versus standard cystoscopy that is large enough to be powered
for oncologic outcomes.

Public health relevance
Project Narrative We will systematically study whether the burden of surveillance cystoscopy can be improved among bladder cancer survivors by replacing invasive cystoscopy with urine testing, ultimately improving their quality of life. We propose a three-site randomized phase 2 trial including 240 patients with early-stage bladder cancer, in which patients will be randomized 1:1:1 to programmatic surveillance with the Xpert bladder cancer urine test, the Bladder EpiCheck urine test, or standard cystoscopy. The primary outcome will be urinary quality of life 1 to 3 days after surveillance, with secondary outcomes including discomfort after surveillance measured on a Visual Analogue Scale, anxiety, number of invasive tests performed and of complications per 1,000 patient years, and the cumulative incidence of recurrence and progression at 12 and 24 months.